Define the role of chromosome 17q gain in neuroblastoma malignancy

PROJECT SUMMARY/ABSTRACT
Neuroblastoma (NB) is the most common pediatric extracranial solid tumor. The cell of origin for NB is
believed to be sympathoadrenal cells that are derived from trunk neural crest cells. Recurring mutations
are exceedingly rare in NB, while chromosome copy number changes are more robust. The most
frequent chromosome copy number change is gain of chromosome 17q (17q+), which occurs in ~70-
80% of NB tumors and correlates with poor survival. Although the gold standard to evaluate if a genetic
abnormality promotes tumorigenesis is to use genetically engineered mouse models, mouse and
human chromosomes do not align. Thus, even though the prevalence of 17q+ in NB has been known
for decades, no study has shown a functional effect for 17q+. We recently optimized a human stem
cell model of NB in which human pluripotent stem cells (PSC) are differentiated toward
sympathoadrenal cells and implanted orthotopically into immunocompromised mice. This model allows
us to introduce genetic changes either at the PSC stage or at different stages during sympathoadrenal
differentiation. In addition, we obtained human embryonic stem cells (ESC) that spontaneously
acquired an extra copy of chromosome 17q. Our Preliminary Data demonstrated gain of chromosome
17q is insufficient to generate tumors in sympathoadrenal cells. However, the combination of MYCN
with 17q+ accelerates tumorigenesis compared to MYCN alone. In addition, we found 17q+ tumors
promote resistance to chemotherapy. Therefore, we hypothesize that chromosome 17q gain
contributes to NB tumorigenesis and malignancy. Here, we propose three Aims using the model
and cell lines described above to: 1) compare the tumorigenic potential of 17q+ and MYCN in immature
cells that give rise to sympathoadrenal cells; 2) determine genes on chromosome 17q that cooperate
with MYCN to accelerate tumorigenesis and promote chemotherapy resistance; and 3) identify
vulnerabilities in MYCN/17q+ NB tumors. Successful completion of these studies will provide critical
insight into the role of chromosome 17q gain in NB tumorigenesis and point to novel therapeutic
strategies to potentially overcome chemotherapy resistance.

Public health relevance
PROJECT NARRATIVE Neuroblastoma has few recurrent mutations but frequently has chromosome copy number changes. Gain of chromosome 17q is the most frequent chromosome copy number change and my proposal seeks to investigate the role of chromosome 17q gain in neuroblastoma tumorigenesis and malignancy.